VERBAL LEARNING AND AGE

Among the goals of this project are to describe adult age differences and changes in memory and learning performance and to investigate psychological processes underlying such age-related performance. This year, the second in a series of aging studies of memory and linguistic integration of related sentences was completed. Preliminary analyses indicate that: (1) the young were able to discriminate somewhat previously presented sentences from congruent sentences not presented, but the elderly were not; (2) the yound were able to reject more false sentences than were the old; (3) the age groups did not differ on verification of inferable information, an index of linguistic integration; and (4) only small differences factoring the young were found in two measures of memory for facts.